Structural Basis and Molecular Mechanism of GPCR-Arrestin Interactions

Project Summary/Abstract
G protein coupled receptors are essentially the molecular messengers of the cell,
transducing signals from outside to inside. The signals are remarkably diverse, including a single
photon, ion like calcium, neurotransmitters and hormones. Humans have more than 800 GPCRs
for recognizing different signals, but only three types of transducers, G proteins, GPCR kinases
(GRKs) and arrestins. GRKs phosphorylate GPCRs whereas G proteins and arrestins directly
bind GPCRs, send the signal to downstream effectors and cause a cellular response. Comparing
structures of GPCR bound to G protein and arrestin will provide valuable insights into the
functional selectivity and guide the design of more potent drugs with better safety profiles. There
are currently >300 structures of GPCR−G protein complex reported but only 8 published
structures of GPCR−arrestin complex, which highlights the relative difficulty in obtaining suitable
arrestin complexes for structural analysis. My lab focuses on the understudied GPCR−arrestin
signaling pathway. We have developed a novel tool which stabilizes GPCR−arrestin complexes
for cryo-electron microscopy studies and used that to visualize how the atypical chemokine
receptor 3 engages arrestins in various ways at near-atomic resolution. For the next five years,
we plan to expand the study to many important GPCR−arrestin pairs to understand the structural
details to aid the design of selective interventions. This study will open the way to a detailed
dissection of the mechanism of arrestin-mediated GPCR signaling but also to structure-based
drug design.

Public health relevance
Project Narrative G protein coupled receptors (GPCRs) module important physiological processes, such as vision, taste, blood pressure regulation, immune response, mood control and so on and are the targets of more than 30% of all therapeutic drugs. I propose to visualize how a key regulatory protein, arrestin, interacts with GPCRs at near-atomic resolution using cryo-electron microscopy. Structural details of various GPCR−arrestin complexes will help dissect the mechanism of GPCR function and guide the design of drugs targeting this specific pathway.